Single-cell analysis of DNA damage, somatic mutation, and gene expression in human Alzheimer’s disease brain

Project Summary
Alzheimer’s disease (AD) displays an age-related disease onset, but the mechanisms by which age
influences disease risk are unknown. DNA damage is a hallmark of normal aging and has been implicated as a
possible pathogenic mechanism in AD. We recently innovated new methods to study the genome of single
neurons from the postmortem human brain. Using these novel technologies, we showed that normal neurons
contain at least dozens of somatic single nucleotide variants (SNVs) per genome at birth. Somatic SNVs
increase linearly in postmitotic neurons after birth, reaching levels in the thousands in old age. Somatic SNVs
can be analyzed by patterns of base-pair substitution, analogous to cancer mutations, where distinct
mutational “signatures” mark tumors exposed to specific mutagens or those with deficiencies in specific DNA
damage repair pathways. This analysis of our data revealed at least two neuronal mutational signatures arising
in neurons from distinct sources: one related to aging generally, another related to oxidative damage in aging
but especially in neurodegeneration. Analysis of the genomic distribution of neuronal somatic SNVs revealed
an enrichment in transcribed regions and in active enhancer elements, suggesting that somatic mutations
directly impact gene expression networks. These preliminary data suggest an approach to exploring
mechanisms of neuronal dysfunction in AD that may be downstream of known risk factors such as protein
misfolding.
In our recently published work, we showed that somatic SNVs are increased in excitatory neurons of
late-stage AD patients. These findings prompted several additional questions. First, at what stage of AD
progression does increased somatic mutation begin? To answer this question. we will use a new and improved
scWGS protocol to perform a comprehensive analysis of patterns of somatic mutation over the course of AD,
including SNV and other types of variants, such as short indels and structural variants. Second, does somatic
mutation result in dysregulation in gene expression? We will apply single-nucleus RNA-sequencing to AD and
control brains to answer this question. Finally, how does the activity of DNA repair proteins impact the
generation of somatic mutations? We will apply a quantitative approach to immunofluorescence staining for
various DNA repair proteins and other marks of DNA damage on brian donors with known levels of somatic
mutation to identify the root causes of mutation in the human brain.
Thus, this proposal aims to understand when somatic mutations occur, what the result of those
mutations are, and what caused them in the first place.

Public health relevance
Project Narrative Alzheimer’s disease (AD) and other neurodegenerative diseases are characterized by age-related loss of neurons in the brain, and afflict about half of individuals over the age 85. Scientists currently have a poor understanding of the causes of these disorders. This study will examine how DNA damage, somatic mutation, and gene expression changes during healthy aging relates to AD, with the goal of better understanding the causes of these diseases so that treatments and cures can be developed. 1